Administrative Core

The purpose of this Core is to provide for the administrative support for the Program Project and, thereby, this Core serves all four Projects and the other two Cores. This Core will provide the interface between the Program Project and the Lerner Research Institute and the Cleveland Clinic. In this capacity, the Core will help ensure that institutional compliance deadlines are met in a timely fashion, such as the filing human subject and animal research protocols. The Core will also provide the interface between the Program Project and NIH by seeing that Progress Reports and other correspondences are organized and submitted on time.